Clinical Studies of Acute Dengue Illness

Dengue virus (DENV) infections are an emerging problem, causing disease in tropical and subtropical countries, including the U.S, with recent outbreaks in Texas, Hawaii and Florida. An increase in the average age of DENV related hospitalizations has been globally recognized with adult disease more commonly recognized, but prospective clinical studies that characterize dengue illness in both children and adults are lacking. Dengue hemorrhagic fever (DHF), a more severe clinical manifestation of DENV infection, has been classified by the WHO into four grades of severity with minimal criteria of capillary leakage and thrombocytopenia. The WHO released revised guidelines for the diagnosis of

Public health relevance
RELEVANCE (See instructions): Dengue virus (DENV) infections are an emerging problem world-wide with several recent introductions of disease into the US. DENV infection can cause severe illness and shock, but early identification of individuals who will develop severe disease is currently lacking. Better modalities for early identification and management guidance in children and adults with DENV infection would have a significant impact on global health.